Biophysics and Biomechanics of the Semicircular Canals

Summary. The present work seeks to advance quantitative understanding of angular motion sensation
by the semicircular canals, with specific attention to biophysics of transduction and signaling in crista
hair bundles. Experiments will be done using a new transgenic mouse strain developed in our
laboratory to image hair bundle deflection and calcium transients in stereocilia, in some cases through
the intact ampulla without disrupting the membranous labyrinth. The specific aims are motivated by
preliminary data localizing stimulus-evoked calcium puncta almost exclusively at the tipse of tall
stereocilia, data demonstrating upward movement of calcium puncta as the stimulus strength is
increased, and data suggesting ultrafast calcium signaling from the transduction site to the cell body.
Specific Aim 1 will localize mechano-electrical transduction channels in the bundle using physiological
stimulation, examine recruitment of channels as the stimulus strength is increased, and map the spatial
distribution of transduction across the surface of the epithelium. Specific Aim 2 will measure axial
movements of stimulus evoked calcium puncta in stereocilia, and examine potential micromechanical
and chemical-kinetic origins. Specific Aim 3 will investigate ultrafast calcium signaling from the site of
transduction at tips of hair bundles over a distance >40µm to the cell body.

Public health relevance
Narrative. Disorders afflicting angular motion sensation by the semicircular canals can be disabling, severely impairing mobility, balance, vision and the quality of life. This research is focused on key biophysical mechanisms essential for transduction and signaling in semicircular canal sensory hair bundles.